Understanding Transplant Relapse of the Myelodysplastic Syndromes through Early Detection of Residual Disease among Hematopoietic Stem Cells

Project Summary
The myelodysplastic syndromes (MDS) are a heterogeneous group of bone marrow failure syndromes
diagnosed in 15,000 patients annually within the United States and collectively carrying a 5-year survival rate of
35%. Hematopoietic stem cells (HSCs) have been identified as the cell of origin for MDS, however their rarity
has largely precluded their meaningful study, especially following treatment where hypocellular bone marrow
samples yield exceedingly few cells to study. Therefore, little is known about their response to treatments,
especially after allogeneic stem cell transplant (alloSCT). In preliminary studies, we have validated a new low-
input targeted sequencing workflow using a panel of more than 250 blood cancer associated genes that can
detect mutations in as few as 20 sorted cells. The long-term goal of this project is to elucidate the mechanisms
necessary for cure of MDS by comparing the response of MDS HSCs to alloSCT in patients who relapse vs. who
are cured. The specific aims are as follows: (1) To assess the potential for the detection of MDS HSCs to predict
for relapse, and (2) to elucidate the molecular and clonal evolution that MDS HSCs undergo to persist following
alloSCT. Specific Aim 1 will apply a novel low-input sequencing protocol we have developed to patient samples
following alloSCT to evaluate the variant frequencies of clinically identified MDS driver mutations in HSCs and
determine whether their detection correlates with relapse. Specific Aim 2 will use mitochondrial lineage tracing
in single-cell DNA- and RNA-sequencing studies to evaluate how both the transcriptional programs and sub-
clonal composition of MDS HSCs may evolve during alloSCT to promote relapse.

Public health relevance
Project Narrative Despite 30 years of advancement in our treatment and understanding of the myelodysplastic syndromes (MDS), the 15,000 patients diagnosed with these conditions every year in the US face two harsh realities: their diagnosis carries a 37% 5-year survival rate, and a bone marrow transplantation is their only curative treatment option. We have developed a new sequencing method capable of detecting treatment refractory MDS stem cells present months prior to relapse after transplant, and we aim to use this technique to understand how the persistence or response of these rare cells drives clinical outcomes. The results from this proposal promise to completely change how patients with MDS are monitored and treated by focusing not on the bulk disease cells, but rather their cellular origins in stem cells.